Administrative Core

The Administrative Core will provide critical centralized grant administration, data processing, and administrative support for the projects and cores. This Core will also serve to amalgamate the investigators, their experimental findings and their ideas, evaluation of research efforts and critically direct the summary efforts toward maintaining a highly integrated program outcome. It functions to: 1). Provide administrative services to the investigators. This includes the management of project supplies, filing, development of memos, meeting minutes and communications covering all operations, including publications; 2) Organize monthly or bi-monthly meetings/conferences of program project personnel; quarterly meetings of the Program Steering Committee; 3). Organize semiannual meetings of the Internal Advisory Board and annual meetings of the External Advisory Board. 4). Maintain integration activities that include data sharing, rapid publication efforts, and identify and institute other novel activities critical to maintaining and strengthening the integration of the program. 5). Provide overall fiscal review, accounting, and real time budgets analyses. This includes reports, verbal communications, reviews and forward-looking projections on expenditures. This core is essential for the program integration and effective communication of the scientific program.

Public health relevance
The Administrative Core is essential for the functions of the Program Project for discovering the role of tumor microenvironment in the breast tumorigenesis and for translating these discoveries into innovative approaches for the diagnosis and treatment of breast cancer.